A SMART design study using patient-based algorithms for multicomponent therapy in chronic low back pain and beyond

PROJECT SUMMARY / ABSTRACT
A wide array of evidence-based approaches is commonly used for the treatment of chronic low back pain
(cLBP). Yet, most studies show that only about one third of patients with cLBP, or really any chronic pain
condition, benefits appreciably from any particular treatment. Given the largely underwhelming effects of
current therapies, chronic pain remains a serious public health problem and there must be a cultural
transformation in how pain is understood, assessed and treated. One possible explanation for the small effect
sizes seen with most of the current treatments for cLBP is that patients are not being adequately matched to
appropriate interventions. Individual factors such as demographics; social determinants of health (SDOH);
cognitive, affective and social factors; and especially, pain mechanisms (e.g., inflammatory, neuropathic,
nociplastic) all impact the experience of pain, level of disability, and response to treatment. Thus, the critical
challenge our team has been addressing for over a decade is: What treatment is best for a particular person?
The need for a personalized medicine approach is at the heart of the research underway at the University of
Michigan (UM) Back Pain Consortium (BACPAC) Mechanistic Research Center (MRC). To address this critical
clinical challenge, our team performed an “interventional response phenotyping study” consisting of a
sequential, multiple assignment, randomized trial (SMART) to evaluate treatments for cLBP from four key
domains: pharmacological, physical therapy and exercise, cognitive-behavioral therapies (CBT), and mHealth
pain self-management. Our preliminary data show that while about 25-30% of participants in our SMART
mechanistic study respond to an assigned treatment, there are powerful predictors of treatment response that
are not always intuitive. For INTERACT, we will expand on and enhance our ongoing longitudinal data
collection and analysis for our unique mechanistic cohort where richly phenotyped participants undergo two
treatments. First, we will enhance the data from the current UM BACPAC SMART participants by recontacting
them and then collecting a more robust measurement of SDOH and early life experiences including
assessment of childhood pain and trauma, as well as collecting additional follow-up data to assess long-term
treatment trajectories (Aim 1). Next, we will leverage the clinical, biomechanical, MRI, performance testing, and
survey data from the UM BACPAC SMART study to develop individualized phenotyping treatment rules (Aim 2)
that will better match patients to treatments. We will then recruit and assess another 500 participants with
cLBP and conduct a phenotype-informed SMART design study to evaluate the added benefit of matching
participants to treatments using the individualized phenotyping treatment rules (Aim 3). Lastly, as the top
preforming site in the BACPAC collaborative trial known as BEST, the UM INTERACT team will be enthusiastic
participants in an INTERACT collaborative trial and offer ideas, infrastructure, and leadership to the network.

Public health relevance
PROJECT NARRATIVE The University of Michigan is proud to be part of the NIH BACPAC initiative as one of three mechanistic research centers (MRCs). Our MRC cohort is unique in that it consists of richly phenotyped individuals with chronic low back pain who have also taken part in up to two standardized treatments and followed over time. Here, we propose enriching and expanding this exciting and rare resource, while also realizing a precision medicine approach that could revolutionize how treatments for chronic pain are chosen.